Building Implementation Science Research Capacity to advance cancer prevention and care in Uganda and Zambia

Project Summary/Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-CA-
24-039: Administrative Supplement for NCI Center for Global Health Research Programs''. While AIDS-related
morbidity and mortality among people living with HIV (PLWH) have decreased substantially with the
introduction of combination antiviral therapy, the now aging PLWH population is at an increased risk of other
comorbidities, including cancer. This has been especially true of AIDS-defining malignancies, though more
recently the risk of developing several non-AIDS-defining cancers (NADCs), including Hodgkin lymphoma and
cancers of the mouth, throat, liver, lung, and anus, has also increased among PLWH. This elevated risk is
partially attributed to known behavioral risk factors among PLWH such as poor diet, low physical activity, and
higher use of tobacco, alcohol, and other substances. The intersection of HIV and cancer presents a significant
challenge in sub-Saharan Africa (SSA) where an estimated 75% of HIV deaths occur and cancer treatment
capacity is limited. There is an urgent need for early primary interventions to prevent cancer among PLWH.
Widely effective interventions have included clinician education and training and targeted behavioral
interventions that prevent and reduce the use of tobacco, alcohol, and other substances. However, there is a
lack of implementation research to properly adopt, integrate, sustain, and scale up these evidence-based
cancer interventions for PLWH within the health systems of SSA. We approach this gap by leveraging the
capacity and resources of two NIH-funded cancer research consortiums in Uganda, Quit4Life+
(5U01CA261624-03) and the Building independent research capacity in HIV-associated malignancies (HIVAM)
(D43TW009759). Together, we aim to build cancer-related implementation science research capacity to
strengthen cancer prevention programming, treatment access, and care infrastructure for PLWH populations
throughout the region. Guided by the WHO health systems building blocks and the Reach, Effectiveness,
Adoption, Implementation, and Maintenance (RE-AIM) evaluation framework, the study includes 3 phases: 1)
Preparation and delivery of cancer-related implementation science research training sessions; 2) Adaptation
and testing of a health systems and service delivery assessment tool to evaluate implementation barriers
impacting Quit4Life+’s behavioral support interventions within the Ugandan and Zambian healthcare systems;
and 3) Evaluation of the assessment tool process and outcomes to inform future programs aimed at
strengthening sustainable models of cancer control for PLWH in LMICs. Study results will be widely
disseminated to healthcare providers, policymakers, and public health practitioners. Primary study partners
include the Center for Tobacco Control in Africa at the Makerere University School of Public Health, the
Uganda Cancer Institute, Fred Hutchinson Cancer Research Center in Kampala and the Keck School of
Medicine of USC.

Public health relevance
Project Narrative The supplemental implementation science training and data collection activities proposed will leverage the Quit4Life+ (5U01CA261624-03) and HIVAM (D43TW009759) projects’ research teams (e.g. research trainees, interviewers, field supervisors, data/records managers) and existing study partners (e.g. district officers, clinical supervisors, clinicians, nurses, counselors) to build implementation science capacity and better evaluate cancer-related interventions and services within local, regional, and national health systems. By adapting and piloting an implementation assessment tool, we aim to assess the effectiveness and feasibility of cancer prevention and care interventions for people living with HIV in Uganda and Zambia. This project will have important implications for policymakers, community leaders, and healthcare workers and ultimately guide future implementation science studies and interventions designed to strengthen cancer health service delivery throughout the African region and in other LMICs.